CLINICAL TRIAL COMPARING HOE 901 INSULIN WITH NPH HUMAN INSULIN IN NIDDM

The primary objective of this study is to compare the safety and efficacy of HOE 901 insulin to that of Human NPH insulin in patients with type II diabetes.